T Cell-Specific BRCA1 Function in Antitumor Immunity and Immunotherapy

ABSTRACT
Women with germline mutations of BRCA1 have about an 80% lifetime risk of developing breast cancer. All
somatic cells in a germline BRCA1 mutation carrier harbor the same mutant copy of the BRCA1 gene, yet BRCA1
research is almost exclusively focused on BRCA1’s role in repair of double-strand DNA breaks in the breast
epithelium. This is due to the cardinal tenet of the current BRCA1 paradigm — increased genetic instability of
the breast epithelium solely drives development of BRCA1 mutation-related breast cancer. In addition, current
prophylactic risk-reducing surgeries are aimed at curtailing tumorigenesis of breast epithelial cells of BRCA1
mutation carriers. In contrast, virtually nothing is known about whether BRCA1 heterozygosity in cells beyond
the breast epithelium could also contribute to BRCA1-related tumorigenesis.
Neoplasia is antagonized by the ability of the immune system to detect and eliminate neoplastic cells. Clearly,
impaired antitumor immunity enables immune evasion and tumor outgrowth. We recently found that women with
BRCA1 germline mutations have less abundant circulating CD8+ T cells versus age-matched donors with wild-
type BRCA1 genes. In support of this clinical finding, heterozygous knockout of Brca1 specifically in CD8+ T cells
of mice is sufficient to attenuate antitumor immunity. Based on our preliminary data, we hypothesize that T cell-
intrinsic function of BRCA1 in enhancing antitumor immunity contributes to the overall tumor
suppressor activity of BRCA1. We further propose that in BRCA1 mutation carriers, increased genomic
instability in the breast epithelium and attenuated antitumor immunity in CD8+ T cells act together to elevate
cancer incidence. To validate this novel hypothesis, we will combine our established team’s tools and expertise
in cancer biology, tumor immunology, and transcriptional regulation through the following three Specific Aims:
(1) Discern the impact of T cell-intrinsic BRCA1 on antitumor immunity and immunotherapy, (2) Elucidate the
molecular basis for BRCA1’s function in antitumor immunity, and (3) Examine BRCA1 mutation-related T cell
deficiency in human samples.
Our proposed work represents a new direction in elucidating a previously unappreciated tumor-suppressing
function of BRCA1 in immune cells. The concept to be validated clearly departs from the prevailing paradigm
regarding BRCA1-related cancer etiology, which is focused on the breast epithelium and DNA repair. From a
translational perspective, our proposed study focusing on BRCA1 in immune cells will likely inform development
of novel immune-boosting strategies for women with BRCA1 germline mutations. Thus, this line of work has
potential for far-reaching and sustained impact on breast cancer cancer risk reduction.

Public health relevance
NARRATIVE By combining the awesome power of mouse genetics, precious clinical samples, and cutting-edge technologies, this multidisciplinary team is poised to illuminate a novel function of T cell-specific BRCA1 in antitumor immunity, immunotherapy, and transcriptional regulation. The proposed work promises to have a far- reaching conceptual and translational impact on the current understanding of BRCA1 tumor suppressor function and development of new cancer prevention options for BRCA1 mutation carriers.